Differential sorting and trafficking of Plasmodium falciparum secreted proteins.

Project Summary: Malaria continues to pose a significant global health threat, with severe cases
primarily caused by P. falciparum leading to diverse clinical complications. In the symptomatic stage of malaria,
the parasite undergoes asexual replication within a parasitophorous vacuole (PV) formed inside the human Red
Blood Cell (RBC). Hundreds of parasite-made proteins are secreted into the PV, and a subset of these proteins
is further exported to the RBC through the Plasmodium Translocon of Exported Protein (PTEX) complex located
at the PV membrane. These exported proteins play a crucial role in modifying the host cell, creating a conducive
niche for parasite growth, and significantly influencing the severity of the disease. The process of how exported
proteins are differentially sorted from PV-resident proteins and targeted to the PTEX complex remains to be
determined. Recent findings indicate that mature N-terminal sequence (NTS) of secreted proteins, exposed after
processing in the endoplasmic reticulum, encodes a promiscuous signal directing secreted proteins either to the
export pathway or to retention within the PV. This proposal aims to unravel the mechanisms underlying this
differential sorting and trafficking.
Two proposed models are under consideration. The first involves accessory proteins recognizing and
binding export-competent NTSs of export-destined proteins, guiding them to the PTEX complex. Conversely,
accessory proteins in this model may bind to export-incompetent NTSs of PV-resident proteins, inhibiting further
trafficking. The second model posits that the chaperone HSP101, a component of the PTEX complex, discerns
between export-competent and -incompetent NTSs, thereby controlling selectivity. Given the diverse nature of
mature NTSs in both varieties of secreted proteins, the central hypothesis of this proposal is that both models
are partially correct; secreted proteins undergo differential sorting with the assistance of multiple sorting proteins
and HSP101 in a stepwise manner. In Aim 1, sorting proteins in the PV will be identified through proximity labeling
and co-immunoprecipitation, using exported-destined and PV-resident reporters. A refined cell fractionation
strategy will be used to isolate the PV compartment, and global protein export will be blocked by genetically
manipulating the parasite for the experiments. The top 5 hits will undergo rigorous characterization to understand
their role in secreted protein trafficking pathways. Aim 2 focuses on investigating the role of HSP101 in secreted
protein sorting. Reciprocal immunoprecipitations of secreted reporters and HSP101 will be conducted. Structure-
guided modifications of HSP101 will be tested for their potential role in cargo sorting.
The applicant aspires to be an expert in protein trafficking pathways of apicomplexan parasites.
Elucidating the Plasmodium protein export pathway using cutting-edge methodologies under the mentorship of
pioneering molecular parasitologist Dr. Dan Goldberg will greatly enhance the candidate's prospects for an
impactful research career.

Public health relevance
Project Narrative: During its replication within human erythrocytes, the malaria parasite Plasmodium falciparum releases hundreds of proteins into the host cell, and these proteins play a crucial role in the development of diverse clinical complications associated with severe malaria. This study will investigate the mechanism governing the selection and trafficking of those proteins at the host-parasite interface, thus enhancing our understanding of this critical pathway for malaria pathogenesis. In the long term, insights gained from this research will inform the efforts of designing therapeutic interventions, ultimately improving our ability to manage and treat malaria.